Integrate neuroimaging, molecular quantitation, and cytoarchitecture to elucidate the development of myelination in human visual cortex.

PROJECT SUMMARY/ABSTRACT
Visual areas show heightened plasticity in the first year of life, making this time period a key window for identifying
and intervening in the case of developmental atypicalities. Myelination is a likely mediator of experience-
dependent plasticity in visual cortex, as it occurs rapidly in the first two years of life and can influence neuronal
communication, learning, and memory. Yet, little is known about the contribution of myelination to the
development of human visual circuits.
To address these gaps in knowledge, the goal of this research is twofold: 1) Using innovative quantitative
magnetic resonance imaging (qMRI), longitudinally measure the microstructural development of the human
visual system during the first year of life, and (ii) Using advanced histological methods in pediatric and adult
samples of visual cortex, determine the development of myelination in visual cortex and validate in vivo metrics
of microstructural development. In three visual areas with distinct functional development (primary V1 in calcarine
sulcus, place-selective cortex in collateral sulcus, and face-selective cortex in fusiform gyrus), I will (i) test the
hypothesis that human visual areas with prolonged functional development (i.e. face-selective area)
exhibit prolonged myelination and (ii) validate whether the development of myelin can be measured with
specific qMRI metrics. First, I will use histology to map the development of myelin across visual cortex (Aim
1). Next, I will use qMRI to determine the in vivo longitudinal development of visual cortex microstructure (Aim
2). Finally, I will validate whether myelination can explain in vivo measures of cortical development using a
combination of in vivo and ex vivo qMRI, quantitative mass spectrometry, and histology (Aim 3). Achieving these
aims will resolve the contribution of myelin to the development of human visual cortex and validate which MR
metrics can be used as potential diagnostic tools in atypical neurodevelopment.
My sponsor, Dr. Kalanit Grill-Spector, is an expert in pediatric in vivo neuroimaging, and our collaborator, Dr.
Mercedes Paredes, is an expert in pediatric ex vivo histology. Their combined expertise and strong mentorship
will guarantee my training goals are met: developing a strong neurodevelopmental research question, completing
the proposed research, and obtaining training crucial to furthering my future career goals. An F31 NRSA
fellowship would enable me to cultivate my neurodevelopmental and human neuroimaging skillsets, progressing
me towards my goal of becoming an academic principal investigator studying activity-dependent myelination in
health and disease to develop interventions in cases of atypical myelination.

Public health relevance
PROJECT NARRATIVE The first year of life is a delicate time in which visual areas are extremely malleable and myelination occurs rapidly, making it a key time period for identifying and intervening in the case of atypical development. This proposal will map myelination of infant visual cortex using histology and neuroimaging methods and link quantitative measures of visual cortex microstructure to myelin. Findings from this research will advance our understanding of the biological underpinnings of neuroimaging methods and lead to the development of non- invasive biomarkers to diagnose atypical neurodevelopment that will ultimately guide therapeutic interventions.